Pathological activation of integrated stress response as a driver of Chronic allograft dysfunction after lung transplant

PROJECT SUMMARY
Lung transplantation is the only viable therapeutic option to extend and improve the quality of life for many
patients with end stage lung disease. However, survival following lung transplantation is the worst among solid
organs with only 80% and 50% of patients alive at one and five years, respectively. Primary graft dysfunction
(PGD) after lung transplantation, resulting from ischemia reperfusion injury, is the predominant cause of poor
lung transplant early outcomes. Chronic lung allograft dysfunction (CLAD) with lung fibrosis is the leading cause
of morbidity and late mortality after lung transplant. Epidemiologic data suggest a strong link between PGD and
CLAD but the molecular mechanisms underlying this association are unknown. Our laboratory has shown that
non-classical monocytes in the donor lung are necessary for neutrophil recruitment to the allograft leading to
PGD after lung transplantation. In parallel studies, we showed that activation of the integrated stress response
in the alveolar epithelium precludes alveolar epithelial differentiation after injury. Based on these published and
preliminary data, we hypothesize that early PGD induces a chronic activation of the integrated stress
response in the airway and alveolar epithelium that precludes epithelial differentiation in response to
injury, predisposing to a risk of CLAD. We will test this hypothesis in three interrelated specific aims.
Aim 1: To determine whether ISR (Integrated Stress Response) mediated activation of ATF4 is necessary
for impaired alveolar epithelial repair after lung transplantation.
Aim 2: To determine whether ameliorating PGD by targeting donor derived nonclassical monocytes
reduces the severity of CLAD.
Aim 3: To determine whether activation of the ISR in the airway and alveolar epithelium in lung
predisposes patients at an increased risk of early CLAD.
We will test our hypotheses in clinically relevant murine models of PGD and CLAD following lung transplantation.
We will credential our findings in humans by applying multi-omic technologies to the analysis of samples collected
longitudinally after lung transplantation. Our studies are designed to credential targets for therapy that can be
administered at the time of transplant to reduce the long term risk of CLAD.

Public health relevance
PROJECT NARRATIVE While lung transplantation is a life-saving treatment for a variety of end-stage lung diseases, long-term outcomes of patients undergoing this intervention are limited due to the development of chronic lung allograft dysfunction (CLAD). We will determine whether drugs, that we have shown to reduce the risk of early graft injury, can reduce the risk of CLAD by reducing activation of stress pathways in epithelial cells lining the lung.